Inferring diploid 3D chromatin structures from bulk and single-cell Hi-Cdata

Project Summary/Abstract The 3D organization of the genome plays a key role in many cellular processes, such as gene regulation, differentiation, and the cell cycle. Assays like Hi-C measure DNA-DNA contacts in a high-throughput fashion. Inferring from such data accurate 3D models of how chromosomes fold can yield insights that are hidden in the raw data. Many methods exist to infer the 3D structures of haploid genomes, but diploid genomes pose a much more challenging problem because Hi-C data does not inherently distinguish between the alleles. Additionally, while single-cell experiments have made clear that chromatin structure exhibits a great deal of heterogeneity within a population, the sparsity of single-cell Hi-C data poses additional difﬁculties for inference. We have recently published a method to infer 3D diploid genomes by building upon a probabilistic framework we previously developed for haploid data. We propose to apply this method to model diploid yeast genomes in order to further characterize mitotic homolog pairing in yeast. We also propose to extend this method to work with single-cell data, and to validate and integrate our method with microscopy of chromatin sites and nuclear proteins. We will thereby provide an integrated 3D model of high-resolution imaging and DNA sequence.

Public health relevance
Project narrative Although the 3D organization of the genome plays a key role in health and disease, and many organisms of interest are diploid, our recently published diploid PASTIS is the only thoroughly validated method capable of inferring the 3D structure of any diploid genome from pairwise contacts measured by assays such as Hi-C [1]. We propose to ﬁrst apply this method in order to visualize and characterize the poorly understood behavior of homologous chromosomes in diploid yeast. Next, we will extend our method to work with single-cell Hi-C data and facilitate a thorough understanding of chromatin structure and function by creating an integrated single-cell model of chromatin structure and several key nuclear proteins.